Multi-Omics and Chronic Kidney Disease: Correlation with Histology

ABSTRACT
Half of all Americans will develop chronic kidney disease (CKD) during their lifetime. Risk for progressive
CKD is particularly high among African Americans: an estimated 7-8% will eventually require kidney
replacement therapy, such as dialysis or transplant. Existing treatment for CKD is inadequate, and far greater
mechanistic insight is required to explain and address heterogeneity in disease progression. The proposed
study will use a combination of innovative methods and omics data to identify biomarkers and pathways that
are clinically relevant, linking blood protein and metabolite levels to kidney outcomes and kidney histology.
The first phase of this grant focused on integrating genetic and metabolomic data in two cohorts of African
Americans, the African American Study of Kidney Disease and Hypertension (AASK) and a subset of BioME,
an electronic medical record-linked biorepository. The initial grant period was highly productive, with more than
22 publications, and a focus on rigorous replication of findings in multiple research and clinical cohorts. The
renewal proposal requests funds for integrating novel proteomic data with existing metabolomic and genomic
data in AASK (proteomic profiling of 7,000 proteins at the baseline visit funded in year 5 of the initial grant
period) and expansion to the Boston Kidney Biopsy Cohort Study (BKBC), a clinical cohort with adjudicated
histological scores of CKD pathology. Our overarching hypothesis is that an integrated approach combining
genetics, proteomics, metabolomics, and histological correlates can yield novel insights into the pathogenesis
and prognosis of CKD. Additional investigation using data from genetics consortia and the Kidney Precision
Medicine Project will permit corroboration of potential causal roles in disease development and compartment-
specific expression of select markers highlighted by our BKBC analyses at single cell resolution, respectively.
If successful, these studies should (a) identify key metabolites, proteins, and networks that provide
information about risk of CKD progression independent of GFR, albuminuria, and other confounders; (b)
identify blood metabolite and protein markers of specific renal histopathologic findings, including interstitial
fibrosis/tubular atrophy (IFTA), glomerular sclerosis, and arterial/arteriolar sclerosis; and (c) determine the
potential causal role of metabolite and protein markers in CKD pathogenesis. The data generated from this
grant would be largely unprecedented in scope, connecting histology and omics, and work in AASK greatly
increases the diversity of populations represented in omic investigations. Methods developed will have broad
applicability, and the investigators are well poised to extend and replicate findings in other cohorts. Finally, this
proposal will be executed by a team with a track record of collaboration and published expertise in each of the
methods outlined in the application, demonstrating a high level of feasibility.

Public health relevance
NARRATIVE This proposed renewal will expand upon the first phase of a highly productive grant integrating metabolomic profiling and genetics in two cohorts of African Americans with chronic kidney disease. The renewal seeks to advance knowledge of biological pathways underlying chronic kidney disease by further integrating proteomic profiling as well as expanding metabolomic and proteomic work to a third cohort of patients with biopsy- confirmed kidney disease and adjudicated histopathology data. The overall goal is to improve the care of the 800 million patients worldwide with chronic kidney disease by enhancing mechanistic insight and clinical utility.